Admin Core

New Jersey Food Testing Program - Food Safety and Defense (2020-2025): Administrative Core Abstract The New Jersey Department of Health (NJDOH) Public Health and Environmental Laboratories (PHEL) is proposing the New Jersey Food Testing Program (NJFTP) as part of the U.S. Food and Drug Administration’s (FDA) cooperative agreement to improve the food testing capabilities and capacity for NJ and to enhance rapid and surge response to any foodborne outbreaks or contaminations. As part of NJFTP organizational structure, the NJFTP Administrative Core (AC) will provide oversight, coordination, and support to the NJFTP initiatives. Specifically, the AC will: 1) lead on strategic planning and management of NJFTP activities, 2) facilitate communication between NJFTP food testing laboratories and the funding agency, the FDA, 3) oversee the testing laboratory and administrative workflow, 4) serve as a liaison between the NJFTP and the FDA, 5) provide budgetary management, and 6) participate and promote NJFTP outreach activities. To achieve these administrative project goals, the AC is overseen by two principal investigators (PIs): Dr. Thomas Kirn, Public Health Laboratory Services (PHLS) Director and Dr. Zhi-Hua (Tina) Fan, Environmental and Chemical Laboratory Services (ECLS) Director. The AC is further guided by two committees: 1) External Advisory Committee (EAC) and 2) Internal Executive Committee (IEC). The EAC will provide scientific guidance and future direction. The IEC will provide resources and solutions to address challenges. The AC will coordinate with the administrative infrastructure and resources within PHEL, including Sample Receiving (SR), Data Administration (DA), and General Administration to seamlessly support the NJFTP activities. AC leadership will rely upon their demonstrated project management abilities and experiences gained from other significant cooperative agreements, including the 2015-2020 Food Safety and Inspection Service-Food Emergency Response Network agreement. The overarching and functional organization structure described here in combination with PHEL’s established project management capability will ensure the proposed project goals will be achieved and results will be delivered in a timely manner.

Public health relevance
New Jersey Food Testing Program - Food Safety and Defense (2020-2025): Administrative Core Abstract The New Jersey Department of Health (NJDOH) is proposing the New Jersey Food Testing Program (NJFTP) as part of the U.S. Food and Drug Administration’s (FDA) cooperative agreement to improve the food testing capabilities and capacity for NJ and to enhance rapid and surge response to any foodborne outbreaks or contaminations. The NJFTP Administrative Core (AC) will provide oversight, coordination, and support to the NJFTP initiatives. AC leadership will rely upon their demonstrated project management abilities and experiences to ensure the proposed project goals will be achieved and results will be delivered in a timely manner.